Novel mechanisms of metabolic reprogramming of reactive astrocytes and brain repair after focal cerebral ischemia

Project Summary
Focal ischemic ischemia (FCI) is a leading cause of human death, however, functional recovery after FCI has
been observed and can be remarkable in both patients and animal models. Due to limited therapeutic choices
for clinical treatment, studying its mechanisms has been an important topic and could provide therapeutic
insights. Astrocytes in normal adult brains referred to as resting astrocytes (RestAs) are quiescent, but they
undergo rapid proliferation, display a `hypertrophic' morphology, exhibit an altered transcriptional profile, and
eventually form glial scars in the peri-infarct region (PIR) after FCI. These phenomena are known as reactive
astrogliosis, and the activated astrocytes are called reactive astrocytes (ReAs). The phenomena of reactive
astrogliosis indicate that the microenvironment constraining the proliferation capacity of astrocytes is removed
and ReAs must adapt to a more metabolically active phenotype to meet the increased biosynthetic and
bioenergetic demands. Accordingly, the current application will study the metabolic reprogramming of ReAs and
its effects on brain repair after FCI. Our preliminary studies discovered that nicotinamide
phosphoribosyltransferase (NAMPT), the rate-limiting enzyme in the NAD+ salvage pathway, is undetectable in
RestAs but is highly upregulated in ReAs after photothrombosis (PT)-induced FCI and oxygen-glucose
deprivation (OGD) of cell cultures. Metabolomic analysis indicated increased metabolites in major metabolic
pathways including glycolysis and pentose phosphate pathway (PPP) in ReAs. Furthermore, we found that
hypoxia inducible factor 1 (HIF1) is an upstream regulator of NAMPT and conditional deletion of NAMPT in
astrocytes caused increased brain damage, neuronal death, and motor function deficits after PT. Because NAD+
and its derivative NADP+ are important determinants of glycolysis and PPP, we hypothesize that NAMPT
upregulation is necessary and sufficient for metabolic reprogramming of ReAs after FCI, thereby mediating
reactive astrogliosis, promoting brain repair and improve stroke outcomes after FCI. Our overall project goal is
to conduct an in-depth study on the metabolic reprogramming of ReAs and its effect on post-stroke brain repair
after FCI. To accomplish our goals, we will use integrated technologies including astrocyte-specific inducible and
conditional NAMPT knockout and overexpression mice and HIF1 knockout mice, stable isotope labeling (SIL),
LC-MS analysis of metabolomic profile, RNA-seq, in vivo two-photon imaging of metabolism, histology and
behavioral tests. We propose three specific aims. Aim 1 will characterize metabolic phenotype and determine
the effect of NAMPT on metabolic reprogramming of ReAs after FCI. Aim 2 will investigate the regulatory
mechanism of NAMPT induction by HIF1 and other potential transcriptional factors (TFs) in ReAs. Aim 3 will
study the effect and mechanisms by which ReAs promote brain repair and functional recovery through metabolic
reprogramming after FCI. We expect our work will elucidate novel mechanisms of ReAs in post-stroke brain
repair in the context of glia-neuron interactions and provide potential therapeutic insights for FCI.

Public health relevance
Project Narrative Focal cerebral ischemia (FCI) or stroke is a leading cause of human disability and death with limited therapeutic options. The current project will investigate the metabolic adaptation of reactive astrocytes (ReAs) and its effect on brain repair after FCI using cell and mouse models. Our study will elucidate novel mechanisms of metabolic reprogramming of ReAs and brain repair and provide potential therapeutic insights for FCI.